Northern Pacific Global Health Leadership, Education, and Development for Early-career Researchers (NPGH LEADERs)

PROJECT SUMMARY
Trainees enter the Launching Future Leaders in Global Health Research Training Program (LAUNCH) with varying levels
of methodologic skills required to become successful scientists: from collecting, cleaning and storing research data, to
analyzing and preparing data for publication. In partnership with the seven LAUNCH consortia, the NPGH LEADERs
program is requesting supplemental funding to lead development and implementation of two-day research methodology
workshops in Bethesda, MD the weekend preceding the 2023 LAUNCH Orientation. Planned for July 8-9, 2023, the
workshops will include one qualitative section and two quantitative sections (one for trainees with little to no experience
with data collection or analysis, and an advanced section for trainees with significant data analysis experience). The
workshop will be open to trainees of all consortia, as well as trainees supported by the Fulbright-Fogarty Program. The
workshops will be led by experienced research methodologists - the majority prior Global Health Fellows/LAUNCH
trainees - with PhDs in quantitative or qualitative fields (e.g. epidemiology, biostatistics, anthropology, social sciences).

Public health relevance
PROJECT NARRATIVE The annual research methodology workshops are an essential opportunity for skills building and networking that helps launch Fogarty trainees into a productive and successful fellowship year contributing to improvements in global health in low- and middle-income countries around the world.